Validating a novel chemogenetic strategy for opioid use disorder

Project Summary
Opioid use disorder (OUD) is a debilitating condition that represents a significant public health
burden. Current treatments are ineffective for many patients because they require lifelong
adherence to a strict medication regimen to be effective. Thus, there is an urgent need to
develop new treatments for OUD in which a single treatment can confer long-lasting protection.
Here we propose to test an innovative new chemogenetic strategy to achieve this by
suppressing opioid-induced dopamine release in the nucleus accumbens, one of the main
mechanisms underlying OUD. In Aim 1, we test whether using adeno-associated viral vectors to
express a novel chemogenetic receptor in the brain can suppress opioid-induced dopamine
release. In Aim 2, we will test whether this approach can selectively reduce opioid consumption
without affecting other behaviors. In Aim 3, we will test whether this approach can extinguish
opioid consumption in animals with a previous history of opioid self-administration. We
anticipate that this study will provide the proof-of-concept necessary to continue with further
refinement of this technology, with the long-term goal of developing a one-time treatment that
can confer lifelong protection against OUD.

Public health relevance
Project Narrative There is an urgent need to develop new treatments for opioid use disorder. Here we propose to test an innovative new chemogenetic treatment strategy for opioid use disorder in mice. The proposed experiments will provide the proof-of-concept necessary to continue with further refinement of this technology in rats and eventually testing in nonhuman primates.